Home Grown: A family-based lifestyle intervention to support healthy development of young children with Down syndrome

While it is well established that healthy eating and physical activity habits are formed early and influence
immediate and long-term chronic health condition risk, there is an absence of available and accessible
prevention and control programs for families of young children with Down syndrome, who have disproportionately
higher rates of chronic health conditions compared to their typically developing peers. The development of early
childhood interventions tailored to address health behaviors for this population are essential and would provide
significant improvement in their overall well-being and quality of life. Therefore, the goal of this R61/R33 project
is to evaluate an adapted healthy lifestyle program, HomeGrown, specifically tailored for families of young
children with Down syndrome for its feasibility (R61 Phase) and efficacy (R33 Phase) in improving practices
around healthy eating and physical activity. The proposed project is highly responsive to RFA-OD-22-010
seeking clinical trial development for co-occurring conditions in individuals with Down syndrome. As part of the
R61 phase, feasibility of conducting a randomized control trial will be assessed with 38 primary caregivers of a
young child (2-6 years old) with Down syndrome. Participants will be randomized (1:1), stratified by child's
biological sex (male/female) and age (2-3; 4-6 years old), to either the HomeGrown intervention or a waitlist
control (6-month delayed start). The primary outcome is feasibility of the HomeGrown program characterized by
accrual, engagement, and retention rates. Secondary study measures consist of children's diet quality and
physical activity and families' use of evidence-based healthy eating and physical activity practices. In the R33
phase, the efficacy of the HomeGrown program will be assessed with 208 primary caregivers with a young child
(2-6 years old) with Down syndrome. Participants will be randomized (1:1), stratified by child's biological sex
(male/female) and age (2-3; 4-6 years old), to either the HomeGrown intervention or a waitlist control (6-month
delayed start). The primary outcomes measures will assess children's diet quality and physical activity between
baseline and post-intervention; secondary outcomes include families' use of evidence-based healthy eating and
physical activity practices. Guided by the RE-AIM framework, process data collected in both phases will be used
to assess reach, representativeness, adoption, and satisfaction. Measures for both phases will be collected at
baseline (0 months) and post-intervention (6-months). The proposed study fills key research gaps in health
promotion initiatives for families of young children with Down syndrome, who are underrepresented in nutrition
and physical activity research and underserved in clinical practice.

Public health relevance
PROJECT NARRATIVE The overall goal of this project is to test an adapted health promotion program, HomeGrown, that leverages home environmental changes to improve the health of young children with Down syndrome. There is a critical need for evidence-based health promotions programs targeting healthy eating and physical activity that specifically address the unique demands of families of young children with Down syndrome. This work would improve inclusion in, and equity of, health behavior promotion efforts previously limited to typically developing children.